Molecular Phenotyping Core

Abstract/Summary - MPC
The Molecular Phenotyping Core will provide analytical tools to the MNORC investigators to
elucidate molecular mechanisms of disease relevant to obesity and nutritional disorders including
structural identification and quantification of metabolites, perform functional metabolic studies
and integrate multi-omic datasets to provide biological context. These include identifying
unknown metabolites, developing new methods for targeted metabolomics in a range of
biological matrices, validating new biological response indicators and providing biological
context to diverse metabolomic measurements by providing bioinformatics analysis and
developing new bioinformatics tools. In addition to providing instrumental infrastructure, the Core
staff will provide consultation and collaboration to apply metabolomics and data analytical
platforms in nutrition and obesity research. The Molecular Phenotyping Core will optimize the
efficiency and cost-effectiveness by providing these services to MNORC investigators through a
centralized laboratory. In the past five years the core has provided standardized analytical
techniques for the analysis of small molecule metabolites such as amino acid, lipid and nucleic
acid metabolites in samples from murine, rodent and human tissues, plasma, and urine, and
cultured cells. New offerings have included novel untargeted metabolomics platforms, metabolic flux
analysis and data interrogation and bioinformatics tools which will enhance the infrastructure available
for the MNORC investigators. Emphasis will also be placed on fulfilling the needs of Investigators
of the MNORC who will gain maximum benefit from the power of molecular analysis. We are
particularly interested in addressing three areas of need: first, applying the unique sensitivity and
specificity of molecular Phenotyping techniques to broaden understanding of nutritional
disorders ; second, the development of innovative techniques for the detection and structural
elucidation of nutrition-related biomolecules; third, provide data integration and bioinformatic tools
relevant to metabolomics studies; and fourt, providing training for graduate students and
postdoctoral fellows with an interest in nutrition research. By centralizing and standardizing
procedures, the Core provides a common set of analytical tools that will lead to a unified
understanding of molecular mechanisms involved in physiologic and pathophysiologic processes
underlying obesity and other nutrition related disorders.